mitoAMPK in exercise benefits

PROJECT SUMMARY/ABSTRACT
Regular exercise promotes physical performance and health, and prevent various types of diseases. These
benefits are largely mediated by responses and adaptations, particularly mitochondrial remodeling, in skeletal
muscle. 5' AMP-activated protein kinase (AMPK) is a bioenergetics sensor that is critical for the maintenance
of metabolic homoeostasis, and AMPK signaling has been linked to mitochondrial remodeling and functional
adaptations under normal and disease conditions. However, the precise mechanism of AMPK signaling in
control of mitochondrial remodeling with subcellular specificity remains obscure. We discovered a physical
association of a novel AMPK complex (α1, β2 and γ1 subunits) with mitochondria (referred to as mitoAMPK) in
and unveiled its activation (T172 phosphorylation) under exercise and ischemic conditions. We have also
obtained preliminary data to show that inhibition of mitoAMPK blocks exercise-induced mitophagy, a key step
in mitochondrial quality control, in skeletal muscle. We now propose a completely novel hypothesis that
mitoAMPK is preferentially activated at energetically stressed mitochondria during exercise, mediating
precision mitophagy of dysfunctional or damaged mitochondria for functional and metabolic
adaptations To test this hypothesis, we propose:
1) Determine if mitoAMPK is preferentially activated at energetically stressed mitochondria in skeletal muscle.
2) Elucidate the role of mitoAMPK in exercise-induced mitophagy.
3) Eetermine the functional role of mitoAMPK in exercise training-induced functional and metabolic
adaptations.
The proposed studies will capitalize on our novel findings of mitoAMPK that reveals completely new
regulatory and functional features of this important signaling molecule in muscle biology and metabolism. The
experimental design and model systems are both conceptually and technically innovative. The findings will
significantly improve the mechanistic understanding of exercise-induced mitophagy and adaptations, with great
potential impact on the future development of therapeutics for treatment and prevention ofchronic diseases,
like type 2 diabetes.

Public health relevance
PROJECT NARRATIVE Regular exercise improves the quality of mitochondria, the power plants, in skeletal muscle with profound health benefits; however, the underlying mechanism(s) remain poorly understood. We have recently discovered physical association of a nutrient/energy sensing enzyme AMPK with mitochondria and obtain preliminary data to show its importance in getting rid of bad mitochondrial. This project will employ the state-of- the-art technologies to elucidate the regulation and function of this mitochondria-associated AMPK, which will help development of effective therapeutics to treat and prevent chronic diseases, such as diabetes.